A Multilevel Characterization of Sensory Cortical Disinhibition in Post-Traumatic Intrusions

Project Summary/Abstract
Intrusive memories of a traumatic experience are prevalent among individuals exposed to trauma and are leading
predictors of the onset, maintenance, and severity of transdiagnostic post-traumatic mental health difficulties.
Clinical accounts of these intrusive memories highlight their vivid, mostly visual, sensory details that emerge
involuntarily to intrude on conscious thought and elicit a spontaneous reliving of the trauma in the “here and
now”. Despite these sensory-rich features, extant biological models of trauma-related intrusive memories (TR-
IMs) have largely overlooked the sensory cortex in favor of a prefrontal cortex-hippocampus circuit. The present
proposal aims to fill this gap through a multilevel characterization of intrinsic sensory cortical disinhibition and its
impacts on large-scale neural networks and the day-to-day phenomenological experience of TR-IMs. Combining
magnetic resonance spectroscopy (MRS), electroencephalography (EEG), and functional magnetic resonance
imaging (fMRI) in trauma-exposed adults (N = 75), this project will link lower levels of inhibitory neural activity
(alpha oscillations) and an imbalance in excitatory/inhibitory neurotransmitter systems (glutamate/GABA) to
perturbations in the intrinsic functional organization of resting-state neural network dynamics. Ecological
momentary assessments (EMAs) of TR-IMs in this sample will further link such sensory cortical disinhibition to
the vivid, sensory-perceptual properties of TR-IMs, offering a novel candidate mechanism for therapeutic
interventions in sensory cortical disinhibition. An additional sample of non-trauma exposed adults (N = 25) with
intrusive memories of non-traumatic negative life events will undergo the same neuroimaging and EMA protocol
to further delineate the specificity of this mechanism to trauma exposure. Taken together, this project will offer
the first multilevel characterization of the sensory system in survivors of trauma, spanning molecules, circuits,
and ecological self-reports, and pave the way for future investigations utilizing neuromodulation to
mechanistically test the proposed sensory cortical disinhibition model of trauma intrusions. Drawing on the
expertise from a complementary team of mentors (Drs. Isabelle Rosso, Fei Du, and Diego Pizzagalli) and
collaborators (Drs. Christian Webb, Joshua Brown, Lauren Bylsma, and Fabio Ferrarelli), the applicant will
receive in-depth, hands-on training in 1) neurochemistry methods and analysis, 2) ecological momentary
assessments, 3) multimodal data integration and conceptual model development, and 4) neuromodulation
techniques for mechanistic and therapeutic research. The acquired data and proposed training plan will launch
the applicant into an independent research career at McLean Hospital, integrating multimodal neuroimaging,
ambulatory clinical assessments, and advanced neuromodulation techniques to develop novel, mechanism-
based interventions for transdiagnostic post-traumatic sequelae.

Public health relevance
Project Narrative Intrusive memories of a traumatic experience are leading predictors of the onset, maintenance, and severity of transdiagnostic post-traumatic mental health difficulties; however, transdiagnostic treatments for such memories are limited as their underlying physiological mechanisms remain unclear. Tuning in to the distinct sensory-rich properties of trauma-related intrusive memories, the current project will test how the neurochemical and electrophysiological regulators of intrinsic sensory cortical activity are related to the day-to-day experiences of vivid trauma-related intrusions. Findings from this work will identify novel candidate targets for neurotherapeutics in the transdiagnostic treatment of intrusive memories in trauma-exposed individuals.